LONG-TERM PLASMA EXCHANGE IN FAMILIAL HYPERCHOLESTEROLEMIA

The vast majority of the subjects treated under this protocol ere part of the NIH FH Regression Study. Half the group were on drug therapy and repeated plasma change and 1/2 on drug therapy only. Subjects undergo coronary angiography at entry, 2, and 6 years. Initially 34 subjects were entered into the study - 17 in each group and twenty-nine underwent the 4 year angiography. Three subjects has bypass surgery, one had a stroke and the other dropped out. This study has now been completed and results will be published.